Investigating the role of altered lung microbiome in fueling Th17 mediated airway inflammation in COPD among HIV-infected individual

Abstract
Chronic Obstructive Pulmonary Disease (COPD) is increasing in prevalence among people living with HIV
(PLWH) as the widespread use of antiretroviral therapy (ART) has increased longevity in this population. With
the highest density of PLWH, Sub-Saharan Africa has experienced dramatic increases in COPD-related
morbidity and mortality. Despite viral suppression, it’s not fully known what drives accelerated lung
function decline in this population. Amidst intense exposure to environmental insults, the airways have
developed robust protective mechanisms which preserve the airway microenvironment, with highly specialized
lung-resident innate and adaptive immune cells fighting off pathogens. However, these protective mechanisms
deteriorate with age, resulting in a progressive decline in lung function and COPD development. This decline is
worse in the setting of chronic HIV infection. Despite a lack of conclusive evidence, persistent airway immune
activation among PLWH possibly drives airway immunosenescence, inflammaging, and progressive lung
function decline. It is probable that in the setting of chronic HIV, contraction of the T-cell immune repertoire
(immune diversity) increases susceptibility to infections, which drives chronic inflammation, immune
exhaustion, and senescence. In this supplementary application, we aim to investigate the effect of HIV on distal
airway immunosenescence and inflammaging among individuals with COPD. We hypothesize that: (1) chronic
HIV infection accelerates age-dependent contraction of airway T cell receptor diversity; (2) and this
reduced diversity is associated with airway inflammation and poor lung function (low FEV1 and FVC).
We will use broncho-alveolar lavage samples from our currently running parent R21 study to; (1) determine the
effect of chronic HIV on airway TCR diversity and (2) correlate airway TCR diversity indices with levels
of inflammaging cytokines in BAL supernatant. This preliminary data will provide a basis to investigate airway
inflammaging among PLWH, supplementing our parent R21 objectives of investigating the association between
lung microbiome and immune profile in the distal airways of HIV-infected individuals with COPD in a viremically
controlled Ugandan HIV cohort.

Public health relevance
Project Narrative A significant reduction in HIV-associated mortality has substantially increased life expectancy, with estimates among people living with HIV (PLWH) now approaching that of the general population. Consequently, there has been increased attention among survivors to the emerging global burden of non-communicable diseases such as chronic obstructive pulmonary disease (COPD), which affects the lungs causing shortness of breath. Sub- Saharan Africa, with the highest density of PLWH, has experienced dramatic increases in COPD-related burden and mortality. It’s not fully known what processes drive airway aging among PLWH. In this proposal, we aim to determine the effect of chronic HIV on airway immune repertoire and correlate airway this immune diversity with levels of inflammaging cytokines in BAL supernatant. This effort will generate preliminary data to provide the basis for investigating mechanisms of airway aging in HIV.